Consequences of Postpartum Exogenous Oxytocin on Maternal-Neonatal Oxytocinergic Signaling and Behavior

Project Summary/Abstract
The administration of exogenous oxytocin (OT) to prevent postpartum hemorrhage (PPH) is a cornerstone of
obstetric care. However, the impact of this practice on oxytocinergic signaling in the offspring remains poorly
understood. Our preliminary studies using a translational rat model that mimics clinical OT infusion for PPH
prevention (PPH-OT) indicate that maternally administered OT may be transferred to the offspring via breast
milk, leading to altered oxytocin receptor (OTR) expression and reduced sociability in male offspring. This project
aims to address the potential consequences of this transfer for offspring neurodevelopment, with a specific focus
on sex-specific outcomes in hypothalamic OTR-OT signaling.
In Aim 1, we will quantify OT transfer from mother to offspring through breast milk. Using stable isotope-labeled
OT (SIL-OT) administered to postpartum rats, we will use mass spectrometry to track SIL-OT in breast milk,
neonatal plasma, and brain tissue (Aim 1a), and we will map the distribution of SIL-OT within the neonatal brain
using MALDI-MSI (Aim 1b). These experiments will reveal the extent and specific brain regions affected by
lactational OT exposure. In Aim 2, we will assess the impact of lactational OT exposure on OTR-OT signaling in
offspring, with a focus on sex-specific responses in the hypothalamus. Guided by preliminary data showing
decreased hypothalamic OTR expression and reduced sociability in male offspring, we will use RNAscope in situ
hybridization to analyze hypothalamic region-specific OTR expression in male and female offspring at postnatal
days 7, 14, and 21 (Aim 2a). Additionally, we will examine c-Fos expression in OT neurons within the
paraventricular hypothalamus (PVH) following social interaction to assess potential sex-specific disruption in
hypothalamic neuronal activation (Aim 2b).
Collectively, this research will fill a significant knowledge gap in our understanding of the broader consequences
of PPH-OT administration. By leveraging a novel animal model and cutting-edge analytical techniques, we aim
to provide insights that could inform the optimization of OT dosing after childbirth, potentially reducing unintended
neonatal exposure and informing the selection of safer uterotonic alternatives. Ultimately, our goal is to enhance
maternal and neonatal wellbeing by ensuring that obstetric practices are informed by a comprehensive
understanding of the physiological and behavioral effects of OT during a critical period of neurodevelopment.

Public health relevance
Project Narrative The widespread use of oxytocin after childbirth to prevent postpartum hemorrhage (PPH) is crucial for maternal safety; however, its effects on neonatal health remain unknown. Our research seeks to determine the extent of oxytocin transfer to offspring through breast milk and its impact on oxytocin receptor signaling in the developing brain. Insights from our translational rat model could inform safer obstetric practices that minimize neurodevelopmental risks for neonates while maintaining effective PPH prevention, ultimately enhancing health outcomes for both mothers and infants.